Programming Offspring Immunity By In Utero Exposure to Maternal Helminth Infection

PROJECT SUMMARY
Millions of pregnant women worldwide harbor at least one type of parasite infection. In countries
where helminth infections are prevalent in pregnant women, infants have reduced response to
immunizations against multiple diseases. Helminth infections in pregnant mothers are implicated
in this reduced vaccine efficacy in infants and children. However, very little is known about the
factors that drive alterations in fetal immune programing and infant immune responses. The
goal of this proposal is to fill this knowledge gap using a tractable experimental system in mice
that we have developed. We leveraged our expertise in parasite-virus co-infection to establish
a model of maternal helminth infection and our goal is to discover mechanisms that underly
difference in fetal immune programming that occur with prenatal exposure to infections. We
found that offspring exposed prenatally to maternal helminth infection have reduced
susceptibility to influenza virus infection. We hypothesize that maternal helminth infection
independent of in utero transmission alters immune programming in offspring through alterations
to maternal and fetal microbiota. We will test this hypothesis with two aims. The first aim is to
determine replication and inflammatory response to influenza virus in the lungs of offspring with
and without prenatal helminth exposure. Because intestinal helminth infections change the
microbiome of infected mice and the fetal microbiome is acquired from the nursing mother, the
second aim is to determine the contribution of the helminth-altered microbiota to changes in
offspring antiviral responses. At the completion of this study, we anticipate identifying
immunological mechanisms underlying transgenerational imprinting of offspring immunity.
Furthermore, this work will inform efforts to improve immune responses in children in helminth
endemic areas to infection and vaccination.

Public health relevance
PROJECT NARRATIVE Millions of pregnant women worldwide are infected with intestinal helminths, but little is known about the impact of prenatal helminth exposure to offspring immune responses. Our research aims to understand the immunological mechanisms that underly differences in fetal immune development with in utero exposure to helminth infection.